ABC-DS MOMs’ Supplement (Modification of Maternal AD risk in DS)

Abstract
Alzheimer disease (AD) is the most common cause of dementia in the general population and the number of
people living with AD is increasing rapidly. As the focus of pharmacologic treatment of AD has shifted toward
prevention trials, there has been increased interest in individuals who have biomarkers (e.g., the ApoE4 allele)
that place them at greater risk for dementia. One group of particular interest is adults with Down syndrome (DS),
almost all of whom will be diagnosed with AD by the age of 70. Virtually all people with DS develop significant
AD neuropathology, especially amyloid plaques by middle age. Early accumulation of amyloid plaques is
thought to arise from overproduction of A, which is derived from the -amyloid precursor protein; the gene for
-amyloid precursor protein (APP) is located on the trisomic chromosome 21. While the mean age for
developing AD among adults with DS is approximately 53 years, there is considerable variability in the age of
onset, ranging from prior to age 40 to over age 70. Therefore, other factors such as genetics, lifestyle, and
comorbid health issues likely contribute to the age of individual AD onset.
In this supplement, “The MOMs’ study: Modification of Maternal AD risk in DS,” we propose to leverage the
currently funded Alzheimer’s Biomarker Consortium – Down Syndrome study (ABC-DS) to pilot a project
focusing on parents of adults with DS, allowing us to address important questions related to the potential impact
of a range of maternal genetic factors on both maternal AD risk and AD risk to their DS offspring. We propose
to conduct a cross-sectional study examining blood-based AD biomarkers (e.g., plasma Aβ1-42, NfL, ptau181,
ptau217) and genetic factors among a cohort of 150 healthy middle-aged and senior men and women whose
adult children with DS are serving as participants in the ABC-DS. The ABC-DS has been following over 400
adults with DS since 2015 and was recently re-funded to increase this cohort to 550 individuals. Results will
demonstrate the feasibility of enrolling parents of adults with DS in a biomarker study. The pilot data will be
used to support the submission of a larger R01 proposal and will provide a rich dataset that can be shared and
made available to other researchers and permit the testing of hypotheses related to the Projects in
U19AG068054.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is a major public health crisis for our aging population. People with Down Syndrome (DS) are at high risk for AD and because of their unique biology and provide an unparalleled opportunity to develop biomarkers of preclinical AD. This proposed pilot project will focus on parents of adults with DS, allowing us to address important questions related to the potential impact of a range of genetic factors on both maternal AD risk and AD risk to their DS offspring.